ISOTOPIC SYNOVECTOMY IN CHILDREN WITH HEMOPHILIA

This protocol attempts to cause cessation of joint bleeding in children with hemophilia who have early target joints by injection of P32 into the synovium.